MI-CURE Research Project

ABSTRACT
Bladder dysfunction is the costliest lower urinary tract disorder and one of the top three negative
effectors on quality-of-life after stroke and Alzheimer’s Disease. Despite decades of research, the
mechanisms by which bladder fullness is sensed are still unknown. A major barrier to developing and
testing novel therapies for bladder dysfunction is our lack of understanding the mechanism of
how bladder fullness is sensed. Understanding these mechanisms is fundamental to develop improved
therpautics and interventions to maintain and improve bladder function. The overall goal of this project is to
understand the basis of pressure sensing and its linkage to afferent nerve activation during bladder filling.
We propose the novel overarching concept that: (1) localized bladder wall contractions drive afferent
outflow through changes in wall tension; and (2) without sufficient stiffness in the extracellular matrix, these
changes in wall tension cannot occur. In essence, we propose that it is the changes in wall tension – not
the transient contraction itself – that drive afferent outflow during filling. Thus, any change in wall
compliance would have significant effects on the sensation of bladder fullness. This concept focuses solely
on the mechanical properties of the bladder, without speculation as to the role(s) of different cell types
involved in the signaling itself. By first understanding how bladder wall compliance alters sensation, we can
then delve deeper into the mechanisms by which compliance is changed, thereby improving our working
knowledge of bladder dysfunction. The specific aims are: 1) Determine the composition and mechanical
properties of both the decellularized extracellular matrix and the intact urinary bladder; and 2) Elucidate the
relationship between bladder wall stiffness, bladder fullness, and sensory outflow to the CNS.
To address this significant knowledge gap, we have assembled an interdisciplinary team of experts
in physiology, cell biology, neurourology, statistics, and clinical urology and have recruited a promising new
investigator to benign genitourinary disease, Dr. Sara Roccabianca. Dr. Roccabianca has unique expertise
in soft biological tissue mechanical characterization, microstructural quantification, and mathematical
modeling of soft tissues. This assembled team from Beaumont Health and Michigan State University,
located in close proximity to each other, form the Michigan Interdisciplinary Center for Urologic
Research and Education (MI-CURE). In addition to the strong benign urology research program using
innovatice and cutting-edge approaches, MI-CURE has an exciting Educational Enrichment Program to
train and mentor all levels of adult learners, from high school students to medical students, to help expand
and enhance benign urology research. MI-CURE is co-directed by the established scientist-physician team
of Drs. Lamb and Chancellor, with clear communication and coordination plans in place. Together,
MI-CURE will foster successful collaborations, education initiaives, and innovative research.

Public health relevance
NARRATIVE The Michigan Interdisciplinary Center for Urologic Research and Education (MI-CURE) scientific research project will focus on understanding bladder sensation. Specifically, we propose that changes in wall tension – not the transient contraction itself – drive afferent outflow during filling and therefore any change in wall compliance would have significant effects on the sensation of bladder fullness. By first understanding how bladder wall compliance alters sensation, we can then delve deeper into the mechanisms by which compliance is changed in benign bladder conditions, thereby improving our working knowledge of bladder dysfunction.